Modulation of Acute Lung Injury by Type I Interferon Signaling

SUMMARY
The proliferation of type 2 alveolar (AT2) cells is a critical step in the regeneration of the alveolar
epithelium after acute lung injury, but the molecular pathways that regulate this process are unclear. Our
preliminary findings strongly suggest that a specific host defense response, type I interferon (IFN-I) signaling,
inhibits the proliferation of AT2 cells. We performed a high-throughput CRISPR screen, unexpectedly finding
that despite its canonical antiviral properties, IFN-I signaling actually reduced the fitness of SARS-CoV-2-
infected respiratory epithelial cells by restricting their proliferation after the initial peak of viral replication and
cytopathic effect. We furthermore found that IFN-I signaling was not only necessary but sufficient for this
antiproliferative response, and that it was also present in AT2 cells derived from induced pluripotent stem cells.
Although IFN-I signaling has been implicated in driving lung pathology during SARS-CoV-2 infection in vivo,
the underlying basis for this effect is unknown. Our in vitro data forms the foundation of our central hypothesis
that IFN-I signaling promotes acute lung injury of diverse causes by inhibiting AT2 cellular proliferation during
alveolar regeneration. In Aim 1, we will identify the molecular effectors that link IFN-I signaling activation to cell
cycle arrest in respiratory epithelial cells. In Aim 2, we will determine whether inhibition of AT2 proliferation and
alveolar regeneration is responsible for the pathogenic effect of IFN-I signaling in a mouse model of SARS-
CoV-2 infection. In Aim 3, we will determine the potential of IFN-I signaling in AT2 cells to modulate alveolar
regeneration after noninfectious acute lung injury. Together, these studies will clarify the fundamental biology
of IFN-I signaling in the alveolar epithelium and facilitate our long-term objective of developing new disease-
modifying treatments for acute lung injury and the acute respiratory distress syndrome.

Public health relevance
NARRATIVE Type I interferon signaling is an important host defense response to viral pathogens, but its persistent activation at late stages of infection can paradoxically worsen lung disease. This proposal seeks to establish the underlying molecular basis for this effect, with the long-term goal of developing new treatments for COVID- 19 and other causes of acute lung injury.